Precision PET attenuation correction for combined PET/MR imaging of cardiac sarcoidosis

PROJECT SUMMARY
Combined PET/MR, enabling simultaneous PET and MRI, has the potential to at least match the diagnostic
performance of reviewing separate PET/CT and MRI scans, in a single integrated exam of the heart. This will
substantially reduce the patient burden, exam costs, and radiation compared to serial imaging on PET/CT and
MRI, and benefit the workup of multiple heart diseases. Further, by enabling accurate spatial overlap of PET
and MR images, and the ability to generate gold standard metabolic measures from extended dynamic PET
scans, PET/MR could outperform interpretation of serial scans. However, quantitative accuracy of tracer
uptake on PET images from PET/MR studies frequently is lower than that from reference standard PET/CT.
The primary cause of this discrepancy are errors in MR-based corrections for PET signal attenuation. MR-
based attenuation corrections suffer from artifacts due to metallic cardiac implants, breathing motion, and
limited lung signal, which can all propagate into the reconstructed PET image. This is an important problem,
since PET/MR may have limited efficacy in the workup of patients with heart diseases if PET image quality and
quantification does not match PET/CT systems. The overall objective of this proposal is to develop a
comprehensive PET attenuation correction scheme, using the signal from an external PET source and the
patient, to enable precision PET imaging during cardiac PET/MR exams. The method utilizes hardware, image
reconstruction, and deep learning algorithms to directly measure and correct for PET attenuation based on
physics principles alone, without using prior data or assumptions. The specific aims include: 1) fabricating a
device that can rapidly position and remove an external PET source in a PET/MR that is practical and safe for
patient imaging, 2) developing algorithms for real-time hardware optimization and deep learning enhancement
that ensure robust PET quantification for all exams, and 3) evaluating the proposed attenuation correction
scheme on the workup of patients with the infiltrating disease, cardiac sarcoidosis. We focus on cardiac
sarcoidosis, as these patients often have a cardiac defibrillator implanted before imaging, particularly
challenging attenuation correction methods, and PET and MRI are the standard of care for workup. We will
assess our algorithms with phantoms, simulations, and prospective FDG-PET/MR and PET/CT studies of
sarcoidosis patients. Successful completion of these aims will enable realization of PET/MR as a
comprehensive integrated workup of cardiac sarcoidosis and heart diseases overall.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the public health because the development of a high performance PET radiotracer attenuation correction strategy for cardiac PET/MR exams has the potential to improve the strength of research and clinical findings based on PET measurements. This will enable PET/MR to provide an accurate diagnosis, prognosis, and therapy response monitoring of cardiac diseases.